Exploring the role of gonadotropins in Down syndrome

PROJECT SUMMARY/ABSTRACT Down syndrome (DS) is a common chromosomal disorder that results from the triplication of chromosome 21. Comorbid medical conditions frequently occur among individuals with DS; however, opthalamic disorders such as keratoconus occurs 6 times more often among this population as compared to the general population. Keratoconus is a known multifactorial, progressive, degenerative disease of the cornea; however, the etiology of the disease remains unclear. Our recent work has found that hormone-regulated Prolactin-Induced Protein (PIP) is a potential biomarker of keratoconus but the link between DS and keratoconus remains unclear. Pathway analysis has further linked comorbid DS and keratoconus through gonadotropins and serum amyloid A1 (SAA), a protein linked in a series of studies to cognitive dysfunction among adults with DS. The proposed study aims to determine and validate the role of gonadotropins in the DS population with the keratoconus co-morbidity with the long-term goal to better understand the underlying mechanisms that result in increased risk for ocular co-morbidities such as keratoconus among this population. This pilot study will include n=90 participants (n=30 DS; n=30 comorbid DS and Keratoconus; n=30 healthy controls). All participants will provide biofluid samples of tears and plasma, which will be assayed on an electrochemiluminescence (ECL) platform. Analyses will be performed using R and SPSS 24 (IBM) in a series of steps. Support Vector Machine (SVM) analyses will be applied to examine the use of biomarkers to detect disease presence (i.e. keratoconus comorbidity). Least absolute shrinkage and selection operator (LASSO) analyses will help with variable selection in order to enhance the prediction accuracy of the models. Biomarkers will include hormone specific (LSH, LH, GNRH, LHR, FSHR, GNRHR) as well as a panel of plasma proteins including biomarkers of inflammation linked with cognitive dysfunction (SAA, CRP, ICAM1, VCAM1, IL-6, IL-10, TNF-α, IL-5, IL-7, Eotaxin-3, TARC, A2M, B2M, FVII, TNC, Adiponectin, FABP-3, IL-18, PPY, TPO and I-309). Diagnosis of keratoconus will be utilized as the dependent variable. If successful, data obtained from this study could help facility the development of a screening tool for detecting individuals with DS who are at risk for development of keratoconus, with the goal of defining potential enrollment into clinical trials.

Public health relevance
PROJECT NARRATIVE Vision disorders occur in nearly all individuals with Down syndrome (DS) with development of ocular co-morbidities such as keratoconus, a cornea dystrophy, occurring 6 times more often in this population as compared to the general population. Recent work from our group has found differences in sex hormones (i.e. androgen and estrogen levels) among individuals with keratoconus as compared to healthy controls but this difference was impacted by age and gender. Information gained from this study will (1) reveal the relationship between gonadotropins among individuals with DS and ocular comorbidities, specifically keratoconus, and (2) provide insight into the association between known plasma biomarkers including serum amyloid A1 and gonadotrophins among those with DS as well as those with comorbid keratoconus and DS.